Core B

PROJECT SUMMARY – Core B
The major goals of the Molecular Biology Core is to provide expert and efficient laboratory services to Project 1
(Saper), Project 2 (Scammell), Project 3 (Fuller) and Project 4 (Dymecki/Vanderhorst). We also anticipate that
our transcriptomics work will inform selective pharmacological targets for Project 5 (Wellman). The major
duties of Core B are management and genotyping of mutant mouse colonies, performing in situ hybridization
(RNAscope), preparation of viral vectors, including the development of new genetic constructs, and performing
single cell (scRNA-seq) and single nuclei transcriptomics (sNuc-seq), including assistance with bioinformatic
analysis of the transcriptomics datasets. By providing these centralized services, Core B will maximize the
chance of success with several of the more complicated molecular techniques proposed in this PPG. Our
years of experience with these methods maximizes the likelihood that the complicated molecular techniques
proposed in this PPG will succeed.